HUMAN GENE MAPPING WORKSHOPS

The Human Gene Mapping (HGM) Workshops are biennial international meetings at which all data pertaining to the human gene map are updated, discussed, summarised and published. They are working meetings organised into committees, each now responsible for the map of a particular chromosome or a general topic, whose chairs and co-chairs gather and analyse the published data on their chromosome throughout the year. The U.K. will host the next two workshops, an intermediate one, HGM10.5 (St. John's College, Oxford, Sept. 1990) for chairs and co-chairs only, and the main one, HGM11 (New Connaught Rooms London, Aug. 1991). With the emergence of the Human Genome Project, the amount of mapping data is rapidly becoming so vast that development of facilities for online continual updating is rapidly becoming so vast that development of facilities for online continual updating of a permanent human gene mapping database are considered to be the highest priority in the organisation of these meetings. Such a database and software interfaces are currently being designed in collaboration with the Welch Medical Library in Baltimore, and will be implemented by the Computer Unit at the ICRF for HGM10.5 and 11. At these meetings the database will be networked from a central server to several workstations per committee. It will include a Human Genome Database and Gene Mapping Reference Library. At HGM10.5, chairs and co-chairs will be trained in the use of this new facility and will use it to update the gene map. From that time onwards it will be available to them online for updating, through HGM11, and thereafter. At HGM10.5 and 11 each committee, together with the committees concerned with key general matters such as nomenclature, will be chaired by individuals with experience of that chromosome or topic. It is anticipated that in the period leading to HGM11, other individuals with particular expertise, such as linkage analysis or physical mapping, will be co-opted by the chairs where necessary to form part of larger chromosome committees. AT HGM11 participants will be required to join one or two of these committees and to work with them throughout the meeting. The HGM11 meeting will consist of two days of chromosome committee sessions in which talks and workshops will be held to achieve a consensus map for each chromosome; with an attempt to combine physical and genetic maps where possible. These sessions will be followed by a day of more general discussion meetings, and the final day will be a scientific symposium on recent advances in human genetics. The proceedings of the workshops will be published soon after HGM11 both in hard copy and on diskette.